Characterization and Optimization of a Nanofiber-Hydrogel Composite for Tissue Remodeling

Project Summary
Restoration of soft tissue is a significant challenge facing clinicians. The available reparative options,
whether prosthetic or autologous, present major drawbacks including donor site defects, unpredictable tissue
survival, limited duration of restoration, prosthetic exposure, infection, and fibrosis. Therefore, a critical need
exists for a solution which can replace missing tissue volume while encouraging natural remodeling of soft tissue
over time. We have recently developed an injectable nanofiber-hydrogel composite (NHC) material which is
capable of inducing remodeling of the injected volume into vascularized soft tissue with adipocytes without
relying on exogenous growth factors and cells. However, the mechanisms by which it does so are not yet well
understood.
The goal of this proposed project is to characterize the immune and tissue remodeling kinetics of the
injected NHC material, uncover the mechanism(s) by which it achieves soft tissue remodeling, and optimize its
formulation to enhance this desired outcome. We will first investigate the local immune and tissue remodeling
kinetics of the injected site caused by the NHC. This will include characterizing cell infiltration, healthy
extracellular matrix (ECM) deposition vs. irregular fibrosis and foreign body response, inflammation,
angiogenesis, and adipogenesis. In addition, we will uncover the NHC’s mechanism of instigating soft tissue
remodeling by carrying out single-cell RNA sequencing to identify candidate cell subtypes and activated signaling
pathways and then subsequently confirm them through immune knockout or targeted depletion models to
establish a causal relationship. Gaining insight into how soft tissue remodeling can be accomplished with this
biomaterial system will have wide-reaching implications for the regenerative medicine field as we work towards
creating off-the-shelf biomaterials-based solutions for tissue replacement. Finally, through modulation of physical
and structural properties as well as leveraging our mechanistic understanding, we will optimize the parameters
of the NHC to maximize desired soft tissue remodeling. If successful, this proposal will produce an improved off-
the-shelf biostimulatory NHC with enhanced capacity to achieve natural tissue restoration outcomes as well as
a mechanistic understanding of how to achieve soft tissue remodeling, thereby expanding the ability to treat
patients and allowing scientists to engineer the next generation of biomaterials for tissue replacement.

Public health relevance
Project Narrative The proposed research seeks to understand the mechanism(s) by which a novel nanofiber-hydrogel composite material is remodeled in vivo into vascularized soft tissue by infiltrating host cells. Additionally, we will optimize its formulation to develop an improved off-the-shelf material with enhanced capacity to achieve natural tissue restoration.